Clinical and Neuropathological Characterization of Parkinsonism Related to TBI in Veterans (CANPARK-TBI)

The long-term sequelae of brain injury are being increasingly recognized, and are a major focus of current
research. While severe traumatic brain injury (TBI) has immediate and obvious consequences, even mild
traumatic brain injury (mTBI) and repetitive subconcussive injury can lead to devastating complications,
sometimes decades later. Brain injury plays a significant role in the health of a large number of veterans,
especially those from recent conflicts (Operation Enduring Freedom and Operation Iraqi Freedom) and can
cause a spectrum of neuropsychiatric symptoms that include parkinsonism, psychiatric symptoms, and
dementia.
A number of reports have documented an increased prevalence of parkinsonism in those who have
previously suffered brain injury, but the clinical and neuropathological characteristics of parkinsonism in these
individuals is poorly understood. Until recently, parkinsonism related to TBI was presumed to be due to
Parkinson’s disease (PD), with an associated characteristic pattern of abnormal accumulation of alpha-
synuclein protein. More recent evidence, however, suggests that TBI-related parkinsonism may be clinically
and pathologically distinct from PD. Some cases of parkinsonism related to TBI, for example, have been
associated with atypical clinical and pathological features related to abnormal synuclein deposition, or with
clinical features and a distinct pattern of abnormal deposition of tau protein characteristic of chronic traumatic
encephalopathy. Other cases have shown overlapping clinical or pathological features of more than one
neurodegenerative disease.
In this proposal, we will examine the role that brain injury plays in the development of parkinsonism in
veterans. We will recruit subjects with parkinsonism, with and without a history of head injury who are followed
by the co-PIs in the neurology clinic at the James J. Peters VAMC. The nature, frequency, and severity of the
head injury will be defined by medical record review combined with a validated prospective brain injury
questionnaire. Subjects will undergo rigorous characterization of neurological, psychiatric, and cognitive
symptoms, including measures of severity of parkinsonism, atypical motor and non-motor features, and
environmental exposures (such as Agent Orange and cigarette smoking). We will analyze these data to
characterize the features of parkinsonism in veterans with a history of brain injury. In addition, we will measure
TBI-related serum biomarkers (including neurofilament light chain and tau levels) that have been associated
with neurodegenerative disease severity, to determine the relationship between these biomarkers and clinical
presentation.
Subjects from this cohort will be recruited for brain donation; tissue from brains collected prospectively
will then be studied in combination with existing postmortem brain tissue from parkinsonism and TBI cases in
the Mount Sinai Brain Bank. Brain injury history from postmortem subjects will be determined through review of
medical records and interviews of family members. All post mortem brain tissue will undergo qualitative and
quantitative analysis focusing on alpha-synuclein and tau, the key proteins involved in PD, CTE, and other
forms of degenerative parkinsonism. In each case we will examine the distribution and severity of deposition of
these and other proteins associated with neurodegenerative disease, such as beta-amyloid, and
neurotransmitter markers, and correlate them with the clinical features and brain injury history. We anticipate
that TBI-related parkinsonism will be associated with more severe and atypical clinical features, more widely-
distributed neuropathological changes, and atypical patterns of abnormal protein deposition. These findings will
shed light on the chronic neuropathological processes underlying degenerative parkinsonism associated with
brain injury.

Public health relevance
Brain injury is a major risk factor for the delayed onset of parkinsonism, an issue of critical importance for veterans, many of whom have experienced brain injury as a result of exposure in combat. Very little is known, however, about the clinical or pathological features of parkinsonism related to brain injury. Patients with parkinsonism with and without a history of brain injury will undergo rigorous prospective clinical characterization of their neurological, psychological, cognitive, and other symptoms. In addition, postmortem analysis will be performed on a combination of existing brain tissue and tissue from a subset of subjects in this cohort to determine the neuropathological correlates of brain injury. Qualitative and quantitative evaluations will focus upon alpha-synuclein, the core protein involved in PD, and tau, a protein that is deposited in chronic traumatic encephalopathy and other neurodegenerative disorders. These findings, and the observed correlation between the clinical and neuropathological features, will provide valuable insights into the long-term sequelae of brain injury.